LEARRN: Mentored Collaborative Opportunities Component

PROJECT SUMMARY
A major barrier to integrating healthcare research into practice is that researchers often lack firsthand
experience and knowledge of how healthcare organizations operate in what is becoming an increasingly
complex and demanding environment. LeaRRN will provide formal mentored collaborative opportunities for
rehabilitation researchers to engage with healthcare systems through a learning health systems (LHS) Scholar
Program. The foundations of this program are our partnerships with a diverse group of eight health
systems/organizations that represent the rehabilitation continuum of care and provide rich “laboratories” for
hands-on experiences. The overall objective of the Mentored Collaborative Opportunities component of
LeaRRN is to facilitate the conduct of LHS research that is driven by health system partners’ priorities. This will
be achieved by creating productive and synergistic partnerships between rehabilitation researchers and health
systems. This component has the following specific aims: 1) identify health system priority areas for improving
the quality and value of rehabilitation care, by convening stakeholders and align these priorities with calls for
LHS Scholars and pilot studies; 2) solicit and review applications for LHS Scholars; 3) facilitate productive and
meaningful partnerships between LHS Scholars and health systems; 4) provide ongoing scientific mentoring
for the partnerships; and 5) provide administrative oversight for the LHS Scholar Program. The LHS Scholar
program will provide the researcher with resources and guidance to learn about the context of a health system,
its current processes of rehabilitation care delivery and the data infrastructure to support LHS research. The
LHS Scholar opportunity will also allow researchers to cultivate a meaningful relationship with health system
stakeholders and begin preparatory work to conduct research on a priority topic identified by the healthcare
system. These partnerships will be mentored by LeaRRN faculty, who will offer ongoing guidance as the
researcher and health system formulate a plan to engage in the cycle of learning health systems research. At
the end of the LHS Scholar year, the Scholar and health system will be well-positioned to take the work to the
next level which may include seeking pilot study funding through the LeaRRN pilot study program or through
other funding mechanisms. The LHS Scholar Program provides a mechanism for rehabilitation researchers
and health systems to develop partnerships and formulate plans for addressing high-priority rehabilitation care
issues using LHS research methods. These partnerships will produce novel insights and knowledge that will
ultimately inform and accelerate the implementation of evidence into practice to improve the quality and value
of rehabilitation care at the individual, system, and population level.